Training in HIV Implementation Science and Dissemination in Kenya

Project Summary/Abstract
This supplement will support the development of research capacity in the specific area of HIV and aging under
an ongoing parent training program – the HIV Implementation Science and Dissemination in Kenya (HIV-ID)
(2023-2027). The parent training program leverages a long-standing collaboration between Moi University
College of Health Sciences (Moi University School of Public Health [MUSPH] and School of Medicine [MUSM])
in Kenya and the Academic Model Providing Access to Healthcare (AMPATH) Consortium, a collaboration of
North American and European Universities led by Indiana University. The over-arching aim of the parent
training program is to create sustainable and collaborative capacity for HIV Implementation Science and
Dissemination (HIV-ID) both within academia and at the county-level (equivalent to U.S. states). The
supplement project
The primary aim of this supplement titled “Training in HIV and aging implementation science and dissemination
in Kenya (HIV Aging-ID) is to develop a research workforce in Kenya that is prepared to undertake novel
implementation science research on aging with HIV across the lifespan and specially for older people living
with HIV. The proposed one-year supplement will leverage the HIV-ID parent training program to build research
capacity in HIV and aging by supplementing the HIV-ID core curriculum, bringing on additional program faculty
and offering mentored research opportunities for HIV-ID trainees. The specific aims of the proposed
supplement are: Specific Aim 1. To enhance the HIV-ID curriculum with a dedicated module on HIV and aging.
This module will be added to the HIV short course and include topics at the intersection of HIV and aging:
pathophysiology, co-morbidities including chronic disease, life course epidemiology, and social and cultural
issues including stigma facing people living with HIV at different life stages. All HIV-ID trainees and fellows are
required to complete the HIV short course as part of their core HIV-ID curriculum while the program will also
make these modules accessible as “workshops” that are open to other researchers, clinicians, students and
public health staff in Kenya. Specific Aim 2. To support novel implementation science research on aging and
HIV. We will provide two HIV-ID trainees a tailored mentored research track to develop and implement a project
related to HIV and aging. Examples of such projects could include evaluating clinical data and tools to ensure
appropriate aging-related data are captured; evaluating care delivery strategies for older people living with HIV;
and identifying the unique social determinants of health in caring for older people living with HIV. By the end of
the one-year supplement, these activities will be fully integrated into the HIV-ID parent training program for
sustainability and continued development of a research workforce in HIV and aging.

Public health relevance
Project Narrative Older adults living with HIV (OALWH), aged 50 years and above, are a growing but understudied population especially in low and middle-income countries (LMIC). Research is lacking to guide interventions and care programs to meet the unique needs of this population and the number of scientists and researchers in LMIC focusing on aging with HIV is small. By strengthening in-country educational infrastructure, expanding local human resource capacity in strategic areas, promoting sustained engagement in research, enhancing mentorship capacity, and supporting research collaboration with county health teams, this supplement will build sustainable research capacity for HIV and aging research in Kenya.